Comprehensive assessment of the diastereomer composition of LEQVIO (Inclisiran) to determine how chemical synthesis impacts biological activity

PROJECT ABSTRACT
Nucleic acids are an increasingly popular platform for the development of biotherapeutics to treat and prevent a
wide variety of human diseases. The predominate classes of FDA-approved synthetic oligonucleotide
therapeutics include antisense oligonucleotides (ASOs) and small interfering RNAs (siRNAs). siRNAs are duplex
RNA containing an antisense (guide) strand and a sense (passenger) strand. The potency of siRNA relies on
the ability of the antisense strand to complementarily bind to specific mRNA within the target cell. siRNA drug
development requires overcoming the poor pharmacological properties of nucleic acids, including their rapid
degradation by ubiquitous nucleases and poor drug delivery to target organs. One chemical modification
commonly employed for siRNA involves the conversion of the natural phosphodiester nucleotide linkage into a
phosphorothioate (PS) linkage. This modification confers nuclease resistance and enhances protein binding. A
by-product of this modification is the PS linkage is chiral creating diastereomers. The number of diastereomers
within a PS oligonucleotide scale at a rate of 2n, where n is the number of PS linkages. PS diastereomers are
expected to impact the physiochemical and biological properties of oligonucleotide therapeutics. This has
important ramifications for drug efficacy and drug dosing. Additional considerations include uncharacterized
and/or uncontrolled PS diastereomer compositions adversely impact active ingredient bioequivalence. These
are critical for accurate drug labeling for reference listed drug products and development of generic drug options.
Thus, characterization of the oligonucleotide PS diastereomer composition is highly consequential. Currently
there are five FDA approved siRNAs, four of which have a covalently linked ligand containing three N-
acetylgalactosamine (GalNAc) residues to facilitate drug delivery to hepatocytes. These GalNAc-conjugated
siRNAs have six terminal PS linkages, and thus the final drug product is a mixture of different diastereomers.
Four of the PS linkages are in the antisense strand and two in the sense strand. The number of diastereomers
for these GalNAc-conjugated siRNAs is limited (16 for the antisense strand, 4 for the sense strand), which makes
it plausible to investigate how each diastereomer behaves and contributes to the overall activity of the drug
product. Consequently, the purpose of this proposal is to develop innovative synthetic chemistry,
pharmacological assays, and analytical methods to systematically evaluate the diastereomeric composition of
LEQVIO (Inclisiran), an FDA-approved, GalNAc-conjugated siRNA drug. This will be achieved by determining
the activity of each diastereomer in LEQVIO through stereochemically-controlled synthesis, biological activity
assessment using in vitro and animal models, and accurate characterization of the stereochemical structure of
each diastereomer. Our developed methods will be directly transferable to other synthetic oligonucleotides and
will greatly facilitate the development and assessment of generic oligonucleotide drug products.

Public health relevance
PROJECT NARRATIVE Synthetic oligonucleotide therapeutics are a promising class of biopharmaceuticals to treat various diseases which to date have been undruggable by small molecules or protein therapeutics. This project will develop new and innovative methods to determine the extent, range, and biological activity of phosphorothioate diastereomers for synthetic oligonucleotides. The developed methods will greatly improve the efficiency of developing new synthetic oligonucleotide drugs and enable the development of safe, effective, and affordable generic products.